Promoting spinal cord repair using a polymer-based drug delivery system

ABSTRACT
Traumatic spinal cord injury (SCI) causes devastating neurological deficits and long-term disability due to
detrimental structural and functional alteration in neuronal circuits. Despite recent progress, no effective
disease-modifying treatment is currently available for SCI. This may be because the cellular and molecular
mechanisms that cause or contribute to pathophysiological changes in neuronal structure and function after
SCI are poorly understood. Many studies, including ours, have demonstrated a remarkable convergence
between the structural and functional organization of neuronal circuits and the expression of α2δ subunits of
voltage-gated calcium channels (VGCC). Neuronal α2δ subunits positively regulate synaptic transmission by
increasing plasma membrane expression of VGCC. However, these subunits may also play a pathological role
following axonal injury. Expression of α2δ1/2 increases following axonal injury, resulting in aberrant neuron
activities associated with chronic pain and axon regeneration failure. We recently showed that α2δ1/2
pharmacological blockade through systemic administration of gabapentinoids (e.g., gabapentin and
pregabalin), drugs used clinically to treat various neurological disorders, promotes axon regeneration and
functional recovery after SCI in adult mice. Whereas the beneficial action of gabapentinoids in promoting
neurological recovery after SCI is gaining support, systemic administration of this class of drugs can cause
adverse side effects. More recently, gabapentinoids' rise as drugs of abuse generates concern. Given that
neuronal α2δ1/2 subunits accumulate at the growth cone and presynaptic nerve terminals, targeted
interventions could prove to be more effective than systemic delivery strategies. Our preliminary data suggest
that localized intraspinal delivery of gabapentinoids through biocompatible polymer-based injectable
microspheres favors spinal cord repair while circumventing detrimental side effects and misuse associated with
the systemic administration of this class of drugs. Accordingly, experiments in Aim 1 will implement
electrospray techniques to optimize conditions for microsphere fabrication, consistent drug loading and
homogeneous release profiles. We will further characterize physicochemical properties including porosity,
swelling, drug entrapment efficiency and release profile at predetermined time intervals upon reconstitution.
We will also test microsphere performance and behavior in vitro using time-lapse microscopy of primary
neuronal and macrophage cultures. Aim 2 will test whether localized gabapentinoids delivery at the lesion site
favors axon regeneration and SCI repair. Our multi-layered electrosprayed delivery system will facilitate the
development of novel and more effective strategies creating favorable conditions for neurological recovery
after injury to the mammalian spinal cord.

Public health relevance
PROJECT NARRATIVE Despite recent progress, no effective disease-modifying treatment is currently available for SCI. The beneficial action of gabapentinoids (e.g., drugs used clinically to treat various neurological disorders) in promoting neurological recovery after SCI is gaining support. However, systemic administration of this class of drugs can cause adverse side effects. More recently, gabapentinoids' rise as drugs of abuse generates concern. This study proposes and aims to test the hypothesis that a tunable drug delivery system consisting of biocompatible polymer-based injectable microspheres that enable localized intraspinal delivery of gabapentinoids favors spinal cord repair while circumventing detrimental side effects and misuse associated with systemic administration of this class of drugs.